IMMUNOGENICITY TRIAL OF UBI KIV LIPOPEPTIDE VACCINE COMPONENT P3C541B

The purpose of this study is to evaluate an HIV synthetic lipopeptide candidate vaccine component, at two dose levels, administered subcutaneously in a randomized, double-blinded, placebo-controlled study.